Service to Science Scholars Research Program

To develop innovative and impactful solutions for VA’s complex problems, such as suicide prevention
and treatment of post-traumatic stress disorder, VA needs researchers from diverse backgrounds, especially
Veterans and children of Veterans, engaged in scientific inquiry. This application is to continue the “Service to
Science Scholars Research Program” (SSS-RP) offered by the Clinician Investigator Team (CIT) in the Mental
Health Integrated Care Community at Minneapolis VA Health Care System (MVAHCS), which has a long-term
goal of enhancing the diversity of the VA’s research workforce focused on the mental health and well-being of
Veterans and their families. SSS-RP specifically aims to increase the number of student Veterans (SV) and
military-connected students (MCS) who pursue VA research careers focused on mental health, which is
consistent with the mental health recovery model that promotes the inclusion of people with lived experiences
(Veterans in the case of VA) in development of new services.
To achieve these goals, SSS-RP will continue to provide a 10-week pilot-tested summer research
program to undergraduate and graduate students. The SSS-RP pilot yielded high student participant
satisfaction, successful recruitment of SV and MCS and students from underrepresented groups in sciences,
student-authored presentations at scientific meetings, and successful VA employment in research for some
participants. In this renewal proposal, each SSS-RP cohort will train 6 undergraduate students and 3 graduate
students in high-impact, cutting-edge Veteran mental health research. Each student participant will be provided
a mentoring network anchored by a mentoring triad (comprised of 2 undergraduate students and a graduate
student who serves as a near-peer mentor) and one-on-one mentorship by the CIT faculty mentor, enhanced
with evidence-based practices for high-quality mentorship. Program components will include: (1) mentored
research experience to promote participants’ research skills and identity as scientists, (2) effective mentorship
and training in effective mentorship linked to positive science career outcomes, (3) structured, evidence-based
research curriculum to strengthen participants’ necessary skills to navigate the research environment, (4)
statistical and other education programming to increase disciplinary knowledge and confidence in research
skills, and (5) community building and networking activities to expand students’ mentor and resource networks.
Participants will be surveyed to evaluate the program’s short-term impact (i.e., pre- to post-changes in science
identity, skills, and confidence) and identify strengths and areas for program improvement, as well as followed-
up on annually for five years to assess SSS-RP’s long-term impact. All student participants will complete an
independent research project and present at the Annual SSS-RP Symposium. The program has three aims:
Aim 1: To expand access of undergraduate and graduate students nationwide, with an emphasis on SV
and MCS, to high-quality, mentored research experiences focused on Veteran mental health. Benchmarks of
success: > 50% of participants will be SV or MCS; > 50% will be students from underrepresented groups; and
> 90% will complete and recommend the program.
Aim 2: To bolster student participants’ confidence, knowledge, and intent to pursue research careers
through refinements to an established and pilot-tested summer research program combining hands-on
research experiences, strong mentorship and mentorship training, and an evidence-based research
curriculum. Benchmarks of success: Relative to baseline, participants will report improvements in research
self-efficacy, science identity, mentoring self-efficacy, and intent to pursue a research career.
Aim 3: To increase the number of students, especially SV and MCS, who persist on pathways towards
research careers. Benchmarks of success: > 90% of undergraduates will complete science-related bachelor’s
degrees; > 50% will enter and/or complete relevant graduate programs; and > 30% will enter research careers.

Public health relevance
The Service to Science Scholars Research Program at the Minneapolis VA Health Care System aims to enhance the diversity of the VA’s scientific workforce by encouraging students from different backgrounds, such as Veterans and children of Veterans, to enter research careers focused on improving the health and well-being of Veterans and their families. By exposing students early in education to real-life Veteran-centric mental health research that addresses VA’s important problems, such as suicide prevention and treatment of posttraumatic stress disorder, more students will ultimately pursue research careers and be available to continue working on improving Veterans’ mental health. Research shows that Veterans trust and engage more in mental health care provided by other Veterans. Thus, including Veterans and children of Veterans in VA mission-critical mental health research will bolster the likelihood of future treatments that are innovative and that Veterans trust and engage in.